Pathogenesis and Vaccine Studies Of Simian Immunodeficiency Virus Infection Of Monkeys

With the retirement of the P.I., Dr. Hirsch December 31, 2021, all studies have been terminated. All animals were transferred to other Animal Study Proposals and all reagents such as Simian Immunodeficiency Virus molecular clones and infectious virus stocks were appropriately disposed of or transferred to the NIH AIDS Repository. All properties such as freezers, refrigerators, or centrifuges were emptied of contents and decontaminated before bing transferred to active Principal Investigators within NIAID. Personnel have been relocated to other laboratories.